Early Adversity, Childhood Educational Experiences, and Adulthood Physical Health

PROJECT SUMMARY:
Although the association between educational attainment and physical health outcomes—including leading
causes of mortality like cardiovascular disease—is well known to be large in magnitude, enduring over the life
course, and invariant across sex, race, and ethnicity, there are few existing studies that are capable of
prospectively disambiguating aspects of early education that are most predictive of physical health in adulthood
and thus most productively targeted in intervention and prevention efforts. Likewise, few studies of the school
context are also well positioned to incorporate in the same sample correlated aspects of risk in children's early
home environments that might initiate a developmental cascade resulting in poorer physical health outcomes in
adulthood via childhood educational experiences. To address these limitations, the current application is
designed to leverage the landmark NICHD Study of Early Child Care and Youth Development (SECCYD; 1991-
2006), a large-scale, prospective study of children thus far followed prospectively from birth, to evaluate a life
course model whereby early life adversity is hypothesized to confer risk for intermediate health outcomes
relevant to health risk partially through correlated variation in both a) academic achievement and attainment and
b) educational experiences during childhood (e.g., the quality of educational experiences, both interpersonal and
instructional in nature). Building on an NHLBI-sponsored follow-up of the female sub-sample of the SECCYD
(pending R01HL130103, PI: Bleil, to begin 7/1/16), funding for the current application will enable identical
assessments in the male participants including relevant parameters of health/disease risk. This effort will produce
a high powered study of 750 total SECCYD participants (~50% male; ages 25-30 over study period), assuming
80% return of 940 participants. The follow-up visit will involve assessments in domains of cardio-metabolic and
inflammation known to predict long-term risk for disease derived from a physical examination, blood draw, and
comprehensive medical history/health behavior evaluation. These new measures generated from the current
study will be examined in relation to existing, state-of-the-art assessments of early life environments and
educational achievement/experiences acquired as a part of the original SECCYD data collection on both
genders. Early life adversity will be characterized using measures of childhood SES, infant-mother attachment,
maternal sensitivity, father absence, negative life events, and maltreatment. Academic achievement will be
assessed using teacher-reported and objective assessments of academic skills whereas educational
experiences will be studied using classroom observations along with questionnaire assessments of the quality
of teacher-child relationships. In sum, the proposed study reflects a unique, time-sensitive opportunity to examine
longitudinally the extent to which academic achievement and/or the quality of childhood educational experiences
uniquely predict health risk in adulthood, as well as to explore childhood variables that moderate, and adult
behavioral/lifestyle variables that mediate these prospective associations.

Public health relevance
PROJECT NARRATIVE: Although an abundant literature demonstrates that educational attainment predicts risk for adult onset diseases, no previous studies have been able to determine the degree to which early academic achievement versus early educational experiences per se (i.e., instructional and interpersonal in nature) drive the robust association between adult educational attainment and adult physical health, nor whether childhood educational achievement and classroom experiences are unique predictors of adult physical health and/or serve as a mechanism by which early adversity in the family context foreshadows poorer adult health. In this context, the current study proposes the first evaluation of an integrated model whereby the effects of early life adversity on risk for poorer adulthood health are hypothesized to be partially “transmitted” by childhood educational achievement and experiences. The unique dataset we will be using to test these hypotheses (i.e., the NICHD Study of Early Child Care and Youth Development, focused on a cohort followed prospectively from infancy) will also allow for (a) tests of alternative hypotheses related to childhood health (i.e., early ill health confounds the association between early education and adult health) and family background confounds (i.e., parental education and IQ confound the association between education and adult physical health) and (b) exploratory tests of childhood moderators and adult lifestyle mediators of the association between childhood educational variables and adult physical health risk markers.